Participation Matters: Improving Outcomes in School-Age Children with Communication Disorders through Implementation Science

PROJECT SUMMARY/ABSTRACT
Nearly 20% of school-age children have a communication disorder that limits their ability to participate in
daily life, such as classroom discussions or conversations with peers at school. Speech-Language Pathologists
are essential for improving the communication of children with communication disorders in schools. Intervening
during the school-age developmental period (ages 5-12) is key to leveraging the cognitive, social, and linguistic
growth that occurs during this time. Targeting communicative participation (i.e., the child’s ability to communicate
while taking part in everyday life) has been documented as an effective approach to support children’s
communication and well-being. Directly supporting communicative participation is critical to prioritizing
meaningful life participation as a key focus of speech/language intervention. However, less than 1/5 of Speech-
Language Pathologists focus their intervention on supporting communicative participation. The research-to-
practice gap is clear: researchers have developed a guide that describes how to target communicative
participation as an intervention outcome (Baylor & Darling-White, 2020), but this guide is not being used with
school-age children with communication disorders. This proposal aims to address this gap by examining the
barriers and facilitators influencing Speech-Language Pathologists’ use of communicative participation
intervention outcomes (Aim 1) and analyzing Speech-Language Pathologists’ proposed adaptations to the
communicative participation intervention guide (Aim 2). By using an implementation science approach, this
project directly aligns with the NIDCD Notice of Special Interest in Implementation Science in Communication
Disorders (NOT-DC-24-024) and Theme 4 of the NIDCD Strategic Plan (Translate and implement scientific
advances into standard clinical care). We will use a convergent mixed methods approach that combines the
findings of an online survey (quantitative; Aim 1) and focus groups (qualitative; Aim 2). By partnering with school-
based Speech-Language Pathologists, we aim to understand the barriers and facilitators to using these
intervention outcomes in schools and adapt the intervention guide based on their direct input. This research will
lay the groundwork for future studies focused on reducing the barriers, elevating the facilitators, and
implementing the communicative participation intervention guide in school settings with children with
communication disorders. Focusing on the Speech-Language Pathologists’ critical role in supporting
communicative participation will ultimately benefit the many school-age children currently struggling to express
their ideas and communicate in everyday situations at school.

Public health relevance
PROJECT NARRATIVE Intervention outcomes that focus directly on communicative participation (i.e., communication in everyday life situations) are essential for improving the well-being of school-age children with communication disorders. Although researchers have developed a relevant intervention guide, most Speech-Language Pathologists do not directly target communicative participation, which limits children’s access to effective treatments in this crucial developmental period (ages 5-12). This pre-implementation study uses a mixed-methods approach to (1) examine the barriers and facilitators influencing Speech-Language Pathologists’ use of communicative participation intervention outcomes and (2) adapt a research-based intervention guide for practical use in the school context, with the ultimate goal of implementing this guide to enhance outcomes for school-age children with communication disorders.